Plan to Enhance Diversity

Plan to Enhance Diversity: Summary/Abstract
The overall goal of the HDFCCC Plan to Enhance Diversity is to achieve diversity, equity, inclusion, and
accessibility (DEIA) in the research workforce, including trainees, faculty, and staff, Center leadership, and
advisory boards. To accomplish this, HDFCCC uses an approach that is accountable, engages stakeholders,
promotes institutional change that is individual-centered, and aims to provide increasing opportunities for all.
The HDFCCC supports this goal through the creation of the DEIA Office and dedicated leadership. The DEIA
Office leverage institutional commitment and infrastructure, and which are carried out in coordination with
Cancer Research Training and Education Coordination (CRTEC), Community Outreach and Engagement
(COE), and HDFCCC Administration. Specifically, the DEIA Office strives to (1) create and maintain a system
of accountability for DEIA at the HDFCCC by iteratively collecting and analyzing data, disseminating the data
with transparency, and soliciting stakeholder input for improvement; (2) build and expand capacity for DEIA by
collaborating with HDFCCC leadership groups, coordinating with other DEIA efforts at UCSF, and integrating
COE efforts with community partnerships, and CRTEC efforts with training institutions in the catchment area;
and (3) facilitate recruitment and retention of diverse research staff, trainees, faculty, advisors, and leaders and
to foster their career development.